Polymorphic ApoE at the crossroad of lipid metabolism and inflammation in atherosclerosis

ABSTRACT
Additional novel therapeutic strategies based on better understanding of how specific genetic risk factors
participate in the pathogenesis and pathophysiology of cardiovascular disease are necessary to further reduce
the burden associated with this major cause of death. A major genetic risk factor of cardiovascular disease is
polymorphisms in the APOE gene. ApoE is synthesized in many cell types and the importance of liver-derived
apoE in maintaining plasma lipid homeostasis is well documented. How does apoE (dys)function in other cell
type influences atherosclerosis has not been delineated completely. The goal of this project is to ascertain how
each apoE variant expressed in myeloid cells and adipocytes influences atherosclerosis. Preliminary results
showed that: (i) bone marrow cells from human APOE2 and APOE4 gene replacement mice were less effective
than APOE3 cells to reduce atherosclerosis in ApoE-/- mice; (ii) apoE2 and apoE4 enhance myeloid cell
inflammatory response via distinct mechanisms; and (iii) APOE2 but not APOE3 or APOE4 adipocytes are
dysfunctional with elevated intracellular cholesterol content to accelerate inflammation and atherogenesis. Our
premise is that apoE2 and apoE4 augment inflammation and metabolic dysfunctions through distinct
mechanisms, and in a cell type-specific manner, to accelerate atherosclerosis. Our hypothesis is that apoE2
causes cellular dysfunction through impaired intracellular cholesterol efflux, whereas apoE4 causes myeloid cell
dysfunction by inducing oxidative and ER stress. Aim 1 will test the hypothesis that myeloid apoE2 expression
increases myelopoiesis and promote early stages of atherogenesis, whereas myeloid apoE4 accelerates
atherosclerosis advancement to later stages due to its impairment of efferocytosis and metabolic stress. Single-
cell RNA-seq will be performed on lesion smooth muscle and immune cells at 3 stages of atherosclerosis to
delineate how each apoE variant expressed in myeloid cells influences smooth muscle cell plasticity and lesion
immune cell repertoire to alter lesion composition and enhance atherosclerosis. Follow-up studies will test the
effectiveness of reducing intracellular cholesterol levels in APOE2 bone marrow cells and reducing ER stress in
APOE4 bone marrow cells in atherosclerosis protection. Aim 2 will transplant macrophage-depleted perivascular
adipose tissues (PVAT) from APOE2 and APOE3 mice to the carotid arteries of Ldlr-/- mice to test the hypothesis
that the dysfunctional APOE2 adipocytes recruit inflammatory cells to the PVAT tissue to promote inflammation,
which in turn signals to the vasculature to enhance inflammatory cell recruitment to the lesion area to exacerbate
atherosclerosis. Single-nucleus RNA-seq will be performed to compare how adipocyte-derived apoE2 and apoE3
influences adipocyte plasticity and elicit different immune cell repertoires to the PVAT and vasculature to
modulate atherosclerosis. We will also test the hypothesis that increasing cholesterol efflux in APOE2 adipocytes
will reduce inflammation and atherossclerosis. Novel mechanistic information gained from these studies can be
harnessed to design personalized intervention strategies based on APOE genotype to reduce vascular diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) Genetic and population studies have identified the association between 2 distinct mutations (epsilon2 and epsilon4) in the APOE gene with increased risk and severity of coronary and peripheral vascular disease. This project will establish unique mechanisms by which the expression of the polymorphic apoE2 and apoE4 in myeloid cells and adipocytes contributes to atherosclerosis progression. Completion of this project will yield novel information that can be harnessed to design personalized intervention strategies based on APOE genotype to reduce vascular diseases.